Genome-wide chromatin structure and function in Kaposi Sarcoma tissue

Project Summary/Abstract
The Kaposi sarcoma-associated herpesvirus (KSHV) is an etiological agent of cancer. Among these
malignancies, Kaposi sarcoma (KS) is particularly prevalent in people living with HIV. Central to identifying
potential points of therapeutic intervention is a fundamental understanding of how the virus drives cancer
progression at the molecular level. Since its discovery decades ago, the field has excelled at laboratory studies
of KSHV infection. Particular challenges remain, however, in studying actual tissue. This proposal attempts to
bridge this gap with a focused project that connects key collaborators in the greatest areas of need. By building
on established relationships with a biorepository and leveraging resources at an advanced core facility, this
project aims to study hard-to-find specimens with frontline genomics methods. All experiments will be
performed by undergraduate students. Specific Aim 1 will identify virus-associated host enhancers and
regulated genes in KS tissue. The project will obtain clinical specimens of KS from the AIDS and Cancer
Specimen Resource. Skin lesions will be brought to and processed at the Mount Sinai School of Medicine
Center for Advanced Genomics Technology for multiome single-cell ATAC-seq and single-cell RNA-seq
experiments. The sequencing data of open chromatin and gene expression will be analyzed by a team of
undergraduates from Barnard College. The goal is to identify enhancers and regulated genes modulated by the
presence of viral infection. This will provide a map of chromatin interactions from actual cancer tissue and
represents a transformative step beyond cell culture studies. Specific Aim 2 will identify host super-enhancers
in KS tissue. To complement the open chromatin experiments of Aim 1, Aim 2 will use ChIP-seq to identify
super-enhancers for KS. The same frozen tumor tissue from the AIDS and Cancer Specimen Resource in Aim 1
will be processed. ChIP-seq will be performed using antibodies against BRD4, a host regulator of super-
enhancer activity. The goal is to identify active super-enhancers. This will provide a map of key oncogene
regulatory elements from actual cancer tissue and represents a transformative step beyond cell culture studies.
The AREA Impact Strategy emphasizes student peer mentorship and leadership. This proposal will designate
three students to serve as laboratory mentors and leaders. Along with the principal investigator, the peer
leaders will coordinate experiments and data analysis with other students on the team. This intertwines
mentorship training with the research experience and provides opportunities at multiple levels of engagement.
The overall impact will be identification of potential drivers of KS. Elucidating regulatory architecture and
circuitry will identify enhancers and transcription factors that may be essential for growth and potential targets
in future treatments.

Public health relevance
Project Narrative The Kaposi sarcoma-associated herpesvirus infects cells and causes changes that promote the development and maintenance of cancer; enhancers are pieces of the human genome that turn on and off genes to control cell growth. Mapping enhancers in actual tumor tissue from patients will identify DNA sequences and proteins that may be effective targets in cancer therapy. This project combines a resourced specimen repository, an equipped technological core facility, and undergraduate student research to understand how this virus activates the human genome in patient tumors.